Neurotoxicity in the adult rat following chronic exposure to methamphetamine

Both RNA-sequencing and qRT-PCR analysis revealed significant increases in the mRNA levels of cadherin-1 (Cdh1), glycosylation dependent cell adhesion molecule 1 (Glycam1), and myelin protein zero like 2 (Mpzl2) in the compulsive rats in comparison to non-compulsive rats.
Administration of SCH23390 caused significant dose-dependent reduction in METH taking in compulsive rats. Moreover, discontinuation of SCH23390 treatment led to re-emergence of compulsive METH taking behavior in shock-resistant rats. During period of forced withdrawal from METH, compulsive rats showed higher relapse rate then non-compulsive animals.
We also identified sex-dependent and brain region-specific changes in the expression profile of enzymes involved in DA metabolism.